PHASE I STUDY OF TAXOTERE IN PEDIATRIC PATIENTS WITH ADVANCED NEOPLASMS

A Phase I study to determine the maximum tolerated dose of taxotere in pediatric patients, and to determine incidence and severity of toxicities of the drug, and to conduct pharmacokinetic studies.